Administrative Core

ADMINISTRATIVE CORE PROJECT SUMMARY
The Administrative Core is the central hub for all administrative and communications support. Led by Dr. Jan
Schnitzer, the Administrative Core will create an environment that will facilitate interactions between the Leaders
and Researchers in each of the Projects and the other Cores, the Internal and External Advisory Boards, and
the administrative personnel of the subcontracted entities, the University of Alabama, Birmingham (UAB) and
Michigan State University (MSU). The Core will also support interactions with contract research organizations
that will be performing work related to the projects. Core A will be the primary administrative and fiscal interface
with the NCI and will be responsible for scientific oversight as well as ensuring timely and complete
documentation as required. Additionally, Core A will provide consultation and service to the PPG investigators
in the areas of study design, data analysis, mathematical modeling, simulation, presentation, and interpretation
of findings. This Core will support activities involved in the execution and management of the clinical aspects of
the PPG. Regarding interactions with the other Cores and Projects, Core A will establish monitoring and
documentation protocols for use of the other service cores by project personnel and will be the final arbiter of
any conflicts arising over prioritization of service core usage by project personnel. By monitoring both Core usage
and Project progress, Core A will be poised to efficiently recommend or evaluate proposed changes in service
core procedures and/or services. Dr. Schnitzer is well-suited to direct Core A having previously headed a five-
year multi-institutional, multi-investigator NCI program project grant, and is currently leading a NHLBI five-year
multi- institutional and personnel program project grant focused on developing novel therapeutics to treat
interstitial pulmonary fibrosis. He also served as Scientific Director for the Sidney Kimmel Cancer Center (SKCC)
for nine years and has directed numerous NIH, DOD and California funded research projects. Seasoned
Administrative and program management personnel with whom he has successfully and effectively worked with
for more than ten years will assist him daily.

Public health relevance
CORE A PROJECT NARRATIVE The Administrative Core is the principal organizational component through which the Project Investigators execute their responsibilities. Core A provides administrative and fiscal oversight and management to investigators by performing: grant management; review of project and core resources; personnel management; scheduling and organization of meetings; maintenance of information technology resources; data coordination and analyses, preparation and dissemination of research findings.